Elucidating cerebrovascular disease pathways to cognitive decline with vascular neuroimaging

ABSTRACT
Cerebrovascular disease (CVD) is the second most common cause of dementia and the fifth leading cause of
death in the US. At least half of clinically diagnosed Alzheimer’s disease (AD) dementia patients also have CVD
upon autopsy. Despite this, clinical trial designs and treatments frequently overlook the multi-etiological nature
of cognitive decline. For example, significant progress has been made in identifying and treating AD
proteinopathy through anti-amyloid therapies; however, these do not treat or consider effects from comorbid
CVD pathology. Past and ongoing clinical studies focused on single-etiology disease may thus suffer from
insufficient diagnoses and risk estimates, and the effects of treatment may be obscured. This leaves a critical
gap in dementia research for accurate diagnoses and effective treatments against vascular contributions to
cognitive impairment and dementia (VCID) and AD with comorbid CVD. The knowledge gap is largely due to a
lack of non-invasive vascular markers that can inform on specific CVD processes contributing to VCID and their
progression. While Magnetic Resonance Imaging (MRI) serves as the gold standard non-invasive imaging
modality for evaluation of CVD, commonly employed MRI-based markers in the field, such as white matter
hyperintensities measured on T2-FLAIR, only evaluate non-specific sequelae of CVD (downstream tissue injury).
Furthermore, structural and static markers fail to provide insight into the dynamic vascular and hemodynamic
phenomena that, as observed in animal models, lead to brain tissue injury and cognitive decline. The proposed
project aims to address this gap by utilizing a suite of neuroimaging tools developed by the applicant to
understand CVD processes contributing to VCID and to assess vascular hypotheses in relation to the presence
of any AD proteinopathy in an individual. The PI’s research program has generated novel preliminary data in AD
pathology-positive individuals across the cognitive spectrum indicating presence of intracranial vascular stiffness
and decreased neurovascular flow tone, which may contribute to brain tissue injury and cognitive decline.
Leveraging a unique MRI dataset and newly developed methods, the project will reprocess existing raw data (k-
space) to understand interactions between CVD processes, AD proteinopathy, brain tissue injury, and cognitive
decline. Existing longitudinal data in more than 2,000 participants from ongoing studies, including the WI
Alzheimer’s Disease Research Center (WADRC) and the WI Registry for Alzheimer’s Prevention (WRAP), will
be reprocessed from the raw signal MRI data to provide a detailed spatial characterization of intracranial vascular
stiffness and neurovascular flow tone dynamics in both the macro- and micro-circulation. Our goal is to determine
the impact of vascular disease processes, including vascular stiffness and decreased flow tone, on brain tissue
integrity and cognition in the presence and absence of AD pathology. Ultimately, the discoveries from this project
will provide new insights into specific CVD pathways leading to VCID and will inform treatment strategies for AD-
related cognitive decline, considering the potential confounding effects of underlying comorbid CVD.

Public health relevance
NARRATIVE Clinical dementia is often multifactorial, with concomitant contributions from vascular disease and Alzheimer’s disease (AD); however, the precise mechanisms through which vascular disease impacts cognitive decline, whether in the presence or absence of AD pathology, remain relatively unknown. In this project, we will leverage novel vascular markers obtained from neuroimaging and extensive longitudinal data from well-characterized cohorts to elucidate specific vascular disease processes that contribute to cognitive decline and dementia (with or without AD pathology). Discoveries from this project will also inform the design of clinical trials for interventions targeting both single and multi-etiology from vascular disease and/or AD and related cognitive decline.